Extending neutrophil survival in neutropenia-related pneumonia

Project Summary
Neutropenia-related pneumonias account for 40% of infections at sites other than the bloodstream and are
typically treated with broad-spectrum antibiotics and G-CSF therapy. However, not all patients respond to
these treatments. The long-term goal of this project is to explore an alternative strategy for treating and
preventing neutropenia-related pneumonia by increasing the lifespan of neutrophils in the lungs of neutropenic
patients. Since neutropenia-related pneumonia primarily results from an insufficient number of neutrophils in
the infected lungs to eliminate invading pathogens, prolonging neutrophil survival will increase the neutrophil
count in the infected lungs, thereby enhancing host defense against invading pathogens. Here, it is proposed
that prolonged neutrophil survival can be achieved by targeting Gasdermin D (GSDMD), a pore-forming cell
death executor. The premise of this study is supported by preliminary data on the role of GSDMD in mediating
bacteria-induced neutrophil death. The hypothesis is that inhibiting GSDMD will prevent bacteria-induced
neutrophil death and elevate neutrophil-mediated host defense, thus representing a viable therapeutic strategy
for the treatment of neutropenia-related bacterial pneumonia. To further advance the understanding of the role
and regulation of GSDMD in neutropenia-related bacterial pneumonia and explore its therapeutic potential,
three specific aims will be investigated. (1) GSDMD activation depends on the cleavage of the full-length
protein and the generation of the GSDMD N-terminal fragment (GSDMD-NT). Aim 1 will uncover the underlying
mechanism responsible for GSDMD cleavage and activation in neutropenia-related bacterial pneumonia. (2)
Preliminary data show that GSDMD mediates bacteria-induced neutrophil death in vitro, but it has never been
investigated whether Gsdmd-deficiency in neutrophils can intrinsically lead to their prolonged survival in vivo in
neutropenia-related bacterial pneumonia. Aim 2 will elucidate the role of GSDMD in regulating neutrophil
lifespan in the lungs of bacteria-infected neutropenic mice. (3) Aim 3 will explore GSDMD inhibition as a
therapeutic strategy for treating neutropenia-related bacterial pneumonia. It will determine whether neutrophil
specific Gsdmd disruption or pharmacological inhibition of GSDMD can enhance host defense and mitigate
lung damage. Additionally, the effect of GSDMD inhibition on bacteria-induced death of human neutrophils will
be investigated both in vitro and in vivo using NSG mice. Together, results from this study will confirm
GSDMD-mediated neutrophil death in the lungs as a key regulatory mechanism in host defense and as a novel
therapeutic target for the treatment of neutropenia-related bacterial pneumonia. Furthermore, a better
understanding of the underlying mechanisms responsible for the cleavage and subsequent activation of
GSDMD in bacteria-infected lungs will aid in designing strategies to achieve specific inhibition of GSDMD
activation and GSDMD-elicited cell death in neutrophils.

Public health relevance
Project Narrative Experiments proposed in this study will provide insight into the mechanism of action of GSDMD in modulating neutrophil lifespan in bacteria-infected lungs of neutropenic hosts, with the ultimate goal of solidifying GSDMD and related pathways as novel therapeutic targets for treatment of neutropenia-related pneumonia. This will be an important and necessary complementation to the current antibiotic and G-CSF therapies. Additionally, although the focus of this application is on neutropenia-related pneumonia, the same strategy can be readily applied to other infectious diseases related to neutropenia.